Epitranscriptomic regulation in hematopoietic stem cell niche generation and regeneration

Project summary/Abstract
Hematopoietic stem cells (HSCs) rely on the bone marrow niche. Understanding HSC niche
generation during development and regeneration after injury will help devise ways to promote HSC
function and hematopoiesis. During development, HSCs take residence in the newly established bone
marrow niche and remain there for the rest of the adult life. After injury, the bone marrow niche can
regenerate to support the recovery of HSCs and hematopoiesis. Mesenchymal stromal cells (MSCs)
are key components of the bone marrow HSC niche. However, the mechanisms that regulate the
generation and regeneration of the bone marrow MSCs and HSC niche are poorly understood. N6-
methyladenosine (m6A) epitranscriptomic mRNA modification has recently emerged as an important
regulatory module of gene expression with impacts on many biological processes. We found that
deletion of the key m6A methyltransferase Mettl3 leads to HSC niche generation but not maintenance
defects. Based on our preliminary data, we propose to investigate the role of m6A on bone marrow
HSC niche generation and regeneration. Using the key m6A methyltransferase Mettl3 as an entry
point, we will focus on the role of m6A in HSC niche generation during development and regeneration
after an injury. We will characterize how m6A regulates the bone marrow HSC niche development in
vivo. We will also investigate the role and mechanisms of m6A in bone marrow niche regeneration in
vivo. The results of these studies are expected to not only provide new insight into how m6A regulates
bone marrow HSC niche generation and regeneration, but also have the potential to identify novel
targets to help enhance the bone marrow regeneration and niche function to promote a healthy blood
system.

Public health relevance
Project Narrative Experiments in this proposal are aimed at elucidating the role of m6A mRNA methylation in bone marrow HSC niche generation and regeneration. This may help identify novel therapeutic targets to enhance bone marrow niche regeneration to promote HSC function and hematopoiesis.